Transcriptional Control of Neonatal Heart Regeneration

Project Summary Abstract
Heart disease remains the number one cause of death worldwide, due to the inability of the injured adult heart
to regenerate. We seek to delineate the mechanisms that govern development, disease and regeneration of the
heart and to build upon this knowledge to restore cardiac function during injury, disease and aging. In contrast
to the adult mammalian heart, which lacks regenerative capacity, the neonatal heart can efficiently regenerate
following severe injury. To explore the molecular underpinnings of neonatal cardiac regeneration, we have
analyzed global changes in gene expression and the epigenome during regeneration of the neonatal mouse
heart in comparison to later stage hearts that cannot regenerate. We have also performed single-cell RNA
sequencing of cardiomyocytes and the major non-myocyte cell types from neonatal regenerative and non-
regenerative hearts with or without injury. Integration of these comprehensive datasets has begun to reveal a
“regenerative” chromatin landscape of the heart and the transcriptional activators and repressors of this process.
The overarching goal of this project is to build upon this body of information to elucidate the mechanisms that
control the responses of the neonatal heart to injury and to harness these mechanisms to promote adult cardiac
regeneration and repair. By focusing on regenerative transcriptional circuitry and paracrine signaling
mechanisms, we intend to devise new strategies to enhance cardiomyocyte proliferation and survival,
angiogenesis and other regenerative processes mediated by various cellular constituents of the heart.
Ultimately, the molecular decoding of cardiac regeneration will provide a molecular blueprint for activating
endogenous pathways for cardiac repair and facilitate new strategies for restoring function to the injured and
aging heart.

Public health relevance
Project Narrative Heart disease remains the number one cause of death worldwide, due to the inability of the injured adult heart to regenerate. Since the neonatal heart can efficiently regenerate following severe injury, we seek to understand the molecular basis of the neonatal regenerative response of the heart and its silencing with age to provide the capability of rebuilding cardiac muscle or regenerating the myocardium after injury.